Natural Killer Cell Recruitment and Differentiation

Innate lymphoid cells (ILCs) provide early immunity against pathogens and maintain tissue homeostasis.
The best-studied ILCs are the natural killer (NK) cells that circulate in the blood, tissues, and lymph, and target
virally infected and transformed cells to eliminate them. The type 1 innate lymphoid cells (ILC1s) do not
circulate but reside near epithelial surfaces to protect against pathogens and maintain mucosal barrier integrity.
In the uterine mucosa, we identified an abundant tissue-resident NK subset along with the less frequent ILC1s
and cNK cells. We previously reported that the tissue-resident NK cells are specialized to the uterine mucosa
and makeup 70% of the immune cells before and during pregnancy. Despite extensive research, fundamental
gaps in our knowledge remain regarding the origin, differentiation, and function of tissue-resident NK cells in
the uterine mucosa. Sex hormones such as progesterone induce the uterine mucosa to undergo cyclical tissue
remodeling during the estrous cycle and critical uterine tissue transformation in pregnancy. In addition to
progesterone’s role in reproduction, there is growing evidence of progesterone modulating immune cell function
to affect the outcome of infections at mucosal sites. Indeed, we present preliminary data to support a pathway of
progesterone-induced tissue-resident NK cell differentiation that is mediated through circulating cNK cells in
the uterine mucosa. To test the hypothesis that circulating cNK cells encounter progesterone in the uterine
mucosa, differentiate into tissue-resident NK cells, and are tolerant during pregnancy we propose the following
Specific Aims: 1) Determine the signals that differentiate cNK cells-derived NK cells in the uterine mucosa.
Elucidate if cNK-derived tissue-resident NK cells require direct progesterone signaling to drive normal
pregnancy. 2) Investigate the function of cNK-derived tissue-resident NK cells in pregnancy. Determine if
progesterone abrogates the cytotoxicity of cNK-derived tissue-resident NK cells thereby contributing to
tolerance of the semi-allogeneic fetus. Thus, the goal of these studies is to better understand the tissue-resident
NK cell origin, tissue-specific signals that govern their differentiation, and their function in the uterine mucosal
tissue.

Public health relevance
The sex hormone progesterone regulates the uterine mucosal tissue transformation during pregnancy and modulates the immune system. While tissue-resident NK cells are the most abundant innate lymphoid cells before and during pregnancy, the immune modulatory properties of progesterone on the differentiation and function of these cells remains unknown. Better insight into the progesterone mediated immune modulation will help improve hormone therapy used to treat pregnancy disorders such as infertility, pregnancy loss and preeclampsia.